Scale-up and Toxicity Studies of POEGMA-Uricase

Project Summary
The goal of this Phase II SBIR is to continue development of Gateway Bio’s proprietary alternative for
poly(ethylene glycol) (PEG) for use as a conjugate to stabilize and increase the circulation half-life of biological
therapeutics. PEG is used in a broad range of products, including biopharmaceuticals and cosmetics, causing
increasing numbers of individuals to develop anti-PEG antibodies. Once established in circulation, anti-PEG
antibodies can interfere with PEGylated therapeutics or trigger an allergic reaction, both of which result in
reduced drug tolerability and efficacy. An urgent unmet need has therefore emerged for PEG-free therapeutics,
requiring new moieties capable of producing the same circulation half-life and stability improvements required
for many biotherapeutics. In response to this need, Gateway Bio has developed poly(oligoethylene glycol methyl
methacrylate) (POEGMA), which has short oligoethylene glycol chains distributed along a polymer backbone.
These features eliminate PEG’s immunogenicity, while still providing prolonged circulation half-life and
compound stability. During a previous Phase I SBIR grant, Gateway demonstrated reliable synthesis of POEGMA
as well as conjugation to an FDA approved enzyme drug, uricase, currently marketed as a PEGylated
therapeutic, pegloticase (trade name: Krystexxa™), for the treatment of treatment-refractory chronic gout.
Pegloticase has been linked with high titers of anti-PEG antibodies, leading to severe allergic reactions as well
as reduced drug efficacy. Dynamic light scattering (DLS) showed that both PEG and POEGMA conjugation
increase the hydration radius of uricase with no change in the enzyme’s activity. In vivo pharmacokinetic studies
in mice also showed that both modifications result in dramatic improvements in circulating enzyme at 24, 48, and
72 hours over unmodified enzyme, with POEGMAylated enzyme showing increased serum levels over
PEGylated enzyme. Serum drawn from animals treated with PEG conjugated enzyme contained relatively high
titers of anti-PEG antibodies, including both IgG and IgM species. In contrast, after treatment with POEGMA-
conjugated enzyme, anti-POEGMA antibodies were undetectable. These data provide compelling evidence that
POEGMA can improve the drug properties of biotherapeutics without the fear of immune responses that reduce
efficacy or tolerability of the drug. Here, Gateway Bio proposes a Phase II program to accomplish the following
goals: 1) scaling up production of uricase (Gateway Bio) and POEGMA (with contractor CuraPath, Inc.); 2)
developing a high-volume conjugation method to generate POEGMA-uricase (Curapath); 3) a comparative study
between POEGMA-uricase and pegloticase in a murine model (Duke University subaward); and 4) initial toxicity
and biocompatibility studies to support a pre-IND meeting with the FDA to enable future clinical studies (with
contractor Charles River Labs). These efforts will support the continued development of POEGMA-uricase, as
initial technical and market validation for the company’s novel PEG alternative.

Public health relevance
Project Narrative Polyethylene glycol or PEG is often attached to drug compounds to improve their stability and half-life in circulation. This moiety has been shown to induce the appearance of anti-PEG antibodies in patients, however, leading to reduced tolerability and efficacy of PEGylated drugs. Gateway Bio has developed a PEG alternative, poly(oligoethylene methyl methacrylate) or POEGMA, which has the same drug improvement capabilities without the induction of high antibody levels. Here, we will develop a POEGMA-modified version of a PEGylated drug, pegloticase, to validate the moiety’s capabilities in a drug with known efficacy but with tolerability concerns linked to its PEG modification.